A Sleep Hygiene Intervention to Improve Sleep Health in Urban, Latino Middle School Children

Project Summary/Abstract:
Sleep is essential for optimal health and development. Poor sleep is associated with impaired functioning and
academic performance, and worse health outcomes in children. Latino children are disproportionately present
in urban settings, and due to their exposure to higher levels of urban and cultural stressors, are at greater risk
for poor sleep hygiene and quality. Over the past 3 years, we have demonstrated the acceptability, feasibility
and preliminary efficacy of a novel sleep hygiene intervention, SIESTA (School Intervention to Enhance Latino
Students’ Time Asleep) for improving sleep hygiene and sleep duration in urban Latino middle schoolers in two
geographic areas with a high proportion of urban Latino children at increased risk for poor sleep health:
Providence, Rhode Island, and San Juan, Puerto Rico. SIESTA involves 4 group sessions administered in
school to Latino middle schoolers (6th-8th grade) and two child-caregiver sessions administered remotely by a
bilingual (English/Spanish) trained facilitator from the community. The goal of this application is to administer
a two-site hybrid type 1 effectiveness-implementation design to evaluate SIESTA’s effects on a larger-scale-
for addressing Latino middle schooler’s sleep health, while also assessing implementation determinants. The
first aim of the proposed work is to evaluate SIESTA through a large-scale RCT with urban middle
school students in Providence, RI and San Juan, Puerto Rico. We will enroll 150 Latino children per site
(N=300), and randomly assign them either to the SIESTA intervention, or to the Sleep Education plus Child
Health attention-control condition (9 groups of each of the two conditions, per site; 8-9 students per group). We
will evaluate treatment effects on primary sleep outcomes such as sleep duration, efficiency and sleep onset
latency and on secondary sleep outcomes involving sleep hygiene behaviors, the sleep environment and
sleep-related disturbances and impairment. Assessments will occur prior to, immediately following, and at 4, 8,
and 12 months after the intervention. Over 1 year, we expect SIESTA participants will have improved sleep
outcomes, sleep hygiene behaviors and less sleep-related impairment than Controls. The second aim is to
identify implementation determinants and preliminary implementation outcomes of SIESTA to prepare
for future large-scale implementation in other urban school settings. We will conduct a mixed methods
process evaluation with input from community partners using the RE-AIM framework throughout and following
administration of the RCT. The proposed work builds on a 20-year collaboration between our research
teams in RI and PR, and an investment in advancing knowledge of multi-level factors affecting pediatric health
disparities in children through evidence-based, sustainable interventions. SIESTA has the potential to improve
sleep outcomes in urban Latino children and their daytime functioning, and to address a critical gap of the need
for tailored and effective sleep hygiene interventions for children at greater risk for poor sleep health.

Public health relevance
PUBLIC HEALTH RELEVANCE Sleep is essential for children’s daytime functioning and health, and urban children are at greater risk for poor sleep hygiene and poor quality sleep. SIESTA is a novel intervention to improve sleep hygiene in urban middle school children, and to identify factors that may enhance the acceptability and reach of the intervention for future dissemination. A contextually tailored sleep hygiene intervention has the potential to exert greater improvements in sleep hygiene and sleep outcomes for groups that may be more vulnerable to poor sleep health.